Imaging Core

Project Summary
Yale Cooperative Center of Excellence in Hematology
Imaging Core
The Imaging Core of the YCCEH has provided access to state-of-the-art microscopy for benign hematology to
progressively more users each year. In this renewal, we propose to continue operations with enhancements
including longterm timelapse with decreased phototoxicity, adapted super resolution imaging for hematopoietic
tissues and automated high-throughput microscopy for imaging of 1,000 to 10,000 cells/24 hrs at super-
resolution. Hematopoiesis is a complex and dynamic process involving many heterologous cell types. Due to
the rich spatial and/or temporal information contained in imaging data, imaging is uniquely powerful in
revealing the influences of cellular dynamics and tissue organization on the relevant cells and states. As many
hematopoietic cells are small in size, minimally adhesive, difficult to manipulate genetically, reside in deep
tissues, highly dynamic and/or exceedingly rare, the ability to apply imaging approaches to hematopoiesis
research has been limited to few laboratories with the requisite technical expertise and instrumentation.
YCCEH Imaging Core aims to reduce the high technical hurdle and promote the application of imaging
techniques for hematopoietic research. Yale is the home of many state-of-the-art imaging equipment and
facilities overseen by world-renowned leaders and experts in microscopy. The YCCEH Imaging Core will make
the large array of imaging platforms readily accessible to all investigators with a research interest in
hematopoiesis, locally or nationally. YCCEH Imaging Core will continue to provide its members with access to
state-of-the-art instrumentation including widefield, confocal, 2-photon and flow cytometry imaging. Importantly,
through this Imaging Core, we are making it available as a service, access to and expertise in using innovative
imaging modalities including automated long-term live-cell time-lapse microscopy, optical clearing of tissue and
super-resolution microscopy. The directors of the Core, Drs. Bewersdorf and Guo will act as liaisons between
YCCEH members and the participating facilities and labs and will help identifying most suitable techniques for
individual research projects. The Imaging Core will also support two part time imaging specialists who will train
YCCEH members, maintain the instruments provided by the Bewersdorf and Guo labs and assist with
reagents, sample preparation and data analysis. We will continue to promote the dissemination of knowledge
for imaging in hematopoietic research by organizing symposia, workshops, seminars and training with an
emphasis on students, trainees and other early-stage investigators. Furthermore, the Imaging Core will
continue to develop, optimize and disseminate innovative reporters/probes that are suitable for analyzing
hematopoietic cells by fluorescence imaging and/or flow cytometry. We will continue to encourage YCCEH
members to evaluate various microscopy techniques for their research projects through the user incentive
program, by eliminating the psychological hurdle of investing funds into an unfamiliar technical domain.
Overall, the Imaging Core will facilitate and enable individual hematopoietic researchers to make observations
of their specific hematopoietic cell linages, using approaches that can provide unique structural, functional
and/or dynamic information.